Operation of the COVID-19 Treatment Guidelines Website

The Coronavirus Disease 2019 (COVID-19)Treatment Guidelines have been developed to inform clinicians how to care for patients with COVID-19. Because clinical information about the optimal management of COVID-19 is evolving quickly, these Guidelines have been be updated frequently as published data and other authoritative information become available. The Coronavirus Disease 2019 (COVID-19) Treatment Guidelines is published in an electronic format that can be updated in step with the rapid pace and growing volume of information regarding the treatment of COVID-19. The COVID-19 Treatment Guidelines Panel is committed to updating this document to ensure that health care providers, patients, and policy experts have the most recent information regarding the optimal management of COVID-19. The Coronavirus Disease 2019 (COVID-19) Treatment Guidelines was launched on April 21st, 2020, and has received almost twenty-one million page views through August 2021.